Addressing Colonoscopy Quality to Increase Capacity for Colorectal Cancer Screening (CCSG YR13)

Colorectal cancer (CRC) is the third most diagnosed cancer in the United States. Routine CRC screening is recommended
for individuals ages 45 and older, but is only effective when completed appropriately, like completing diagnostic
colonoscopy after a fecal immunochemical test (FIT). Effectiveness is further impacted by colonoscopy quality. In 2007, a
standardized colonoscopy reporting and data system (CO-RADS) was developed using the key indicators for continuous
quality improvement identified by the Multi-Society Task Force on Colorectal Cancer (MSTF-CRC). Based on the
literature, some variability in the quality of colonoscopy provided in clinical practice is expected, but there is an urgent
need to standardize colorectal early detection screening services, particularly as we consider how best to address
colonoscopy capacity issues in underserved settings.
Our long-term goal is to ensure the quality of colonoscopies in communities where capacity may be limited. Our overall
objective is to determine what resources for colorectal cancer screening are available and the quality of service by a
range of provider specialties and types. Our rationale for the proposed research is e to improve the effectiveness of
colonoscopies in CRC screenings by impacting cecal intubation rates, adenoma detection rates, mean withdrawal time,
and adequate bowel preps.
We plan to accomplish our overall objective for this project through the following three specific aims:
1. Identify the challenges for colonoscopy completion in rural geography. The emphasis in this aim is gaining
the knowledge about service availability and patient need from a population perspective.
2. Examine providers’ alignment with guideline recommendations for screening and frequency. The study
focus of this aim is the variability in screening performance based on provider type.
3. Developing a new endoscopy training program for physicians completing a general surgery residency. The
training program will address the major areas of improvement needed based on the findings from the
previous aims.
With respect to outcomes, we expect to identify the full complement of response elements which determine the overall
quality of colorectal cancer screening services. Such results are expected to vertically advance the outcomes of screening
interventions and maximize cost-effectiveness. Equally important, the results are expected to have a positive impact
because it is probable this highly specific and sensitive training model will save resources that are currently strained.

Public health relevance
Project Narrative Effectiveness of Colorectal cancer screening and diagnostic follow up are influenced by colonoscopy quality. In 2007, a standardized colonoscopy reporting and data system (CO-RADS) was developed using the key indicators for continuous quality improvement identified by the Multi-Society Task Force on Colorectal Cancer (MSTF-CRC) to serve as a quality improvement instrument and to provide referring physicians with a colonoscopy report demonstrating the quality of the examination. Access to high quality colonoscopies have been linked to reduced incidence and CRC-related mortality, however, most studies are from urban and suburban academic medical centers, this analysis aims to provide more recent data describing colonoscopy quality in large, rural colorectal screening programs.